Clinical Core

CORE SUMMARY
The success of the entire program is contingent upon the availability of human specimens that will allow us to
utilize allergen epitope-specific reagents to examine the role of allergen epitope-specific T cell responses in the
pathogenesis and treatment of allergic diseases. To fulfill this need, the Clinical Core resource will provide
peripheral blood and airway samples for T cell studies from well-characterized allergic and asthmatic subjects
to be used in each of the scientific projects. As specifically suggested by the RFA, our approach will utilize
either samples derived from NIAD-funded clinical networks and collaborators, or well-characterized samples
specifically collected at LJI, most of which are already available in-house at LJI, providing a significant cost
savings. Likewise, for the samples derived from clinical networks and collaborators, we rely on established
collaborations and ongoing studies. Therefore, we are confident that the target cohorts will be successfully
enrolled, and additional scientific input will be available, enabling the most robust and compelling studies. The
Clinical Core will provide a centralized resource for accrual and inventory management of human PBMC,
plasma and airway samples, and will ensure the quality and uniformity of handling of the samples received.
These functions are crucial to provide a strong foundation for the studies described in the proposed projects.
The Clinical Core will work closely with the Administrative and Data Management Cores, the individual
Projects, and the various clinical subcontractors to enable success of all objectives in this program. This Core
will be responsible for managing our inventory of human specimens, submitting and updating IRB protocols for
current and new human subjects research, oversight of subject recruitment, quality control of clinical
information, and HLA typing of donor samples.